Risk Factors for End-Stage Glenohumeral Osteoarthritis

Project Summary/Abstract
Glenohumeral osteoarthritis (OA) can be as debilitating as hip or knee OA, and in the US, shoulder
arthroplasty rates for OA are rising more rapidly than hip and knee arthroplasty. Yet few studies have
investigated glenohumeral OA risk factors, resulting in insufficient insights to guide evidence-based prevention
and treatment strategies. For OA at other joints, many risk factors are known, including sex, occupation, and
genetics, but effects can vary considerably by joint type. Therefore effects on glenohumeral OA cannot be
inferred without studies specific to the shoulder. While occupational risk factors for shoulder pain have been
identified, there has been limited investigation of factors that specifically effect glenohumeral OA. Moreover,
the genetics of glenohumeral OA is an unexplored area. Shoulder arthroplasty is also strongly correlated with
hip and knee arthroplasty, and is known to be more common in patients with a history of shoulder instability.
But estimates of the absolute risk of shoulder arthroplasty and how this risk differs across patient populations
has not been well-defined. This information could improve patient counseling, and could indicate opportunities
for early evaluation of OA in high-risk patient groups. Our central hypothesis is that glenohumeral OA results
from a mix of modifiable (occupation) and non-modifiable factors (age, sex, genetics), and that these factors
can be used alongside surgical history to produce informative risk predictions for glenohumeral OA. As no
sufficiently large studies systematically capture radiographic measures of glenohumeral OA, our study will
focus on shoulder arthroplasty as a measure of end-stage glenohumeral OA. Our objectives are to determine
associations of occupational exposures with OA-related shoulder arthroplasty risk (Aim 1), identify genetic
variants associated with risk of OA-related shoulder arthroplasty (Aim 2), and develop prediction models for 5-
year and 10-year risk of OA-related shoulder arthroplasty (Aim 3). Across all aims we will use the UK Biobank
(UKB), a population-based, 500,000-person cohort with more than a decade of prospectively linked hospital
records capturing diagnoses and procedures, including >1200 OA-related shoulder arthroplasty cases. For Aim
1, we will link a novel job exposure matrix to UKB job titles to measure shoulder-specific occupational tasks.
For Aim 2, we will combine whole-genome sequencing data available in UKB and the US-based All of US
cohort to conduct an innovative sequencing-based genome-wide association study for OA-related shoulder
arthroplasty. For Aim 3, we will leverage both the UKB and the US Healthcare Cost and Utilization Project to
develop prediction models for us in both the general population, and specific high-risk patient populations. An
understanding of glenohumeral OA risk factors is critically needed to allow informed design of prevention
approaches. As shoulder arthroplasty is strongly correlated with OA at other joints, better understanding of
genetic influences of glenohumeral OA can provide deeper insights regarding OA etiology. Findings from this
study can enable better prediction of glenohumeral OA, improving patient counseling in the future.

Public health relevance
Project Narrative Glenohumeral osteoarthritis is a leading cause of shoulder pain and disability, but a lack of investigation of glenohumeral osteoarthritis risk factors has resulted in insufficient insights to guide evidence-based prevention and treatment strategies. Our proposal aims to leverage multiple existing data resources to determine associations of occupational exposures with osteoarthritis-related shoulder arthroplasty risk, identify genetic variants associated with risk of osteoarthritis-related shoulder arthroplasty, and develop prediction models for osteoarthritis-related shoulder arthroplasty. An understanding of glenohumeral osteoarthritis risk factors is critically needed to inform design of prevention approaches, provide new insights into osteoarthritis etiology, and to improve patient counseling in the future.